Innovative strategies to enhance DCreg function and promote IS drug-free kidney transplant survival

P01 Project 1 Summary
Therapeutic regulation of innate immunity remains underexplored. Our overall hypothesis is that graft survival
can be extended and immunosuppression (IS) withdrawn in NHP kidney transplantation by innovative strategies
incorporating cutting-edge technologies to enable 1) selective inhibitory targeting of DCs in situ, or 2) adoptive
transfer of autologous regulatory DCs (DCregs) pulsed with donor small extracellular vesicles (sEVs). The
regimens we propose (co-ordinated by administrative Core A, synergistic with Project 2 and dependent on each
scientific Core) will (i) provide new mechanistic insight into the induction and maintenance/stability of donor-
specific unresponsiveness and (ii) potentially identify novel predictive biomarkers. In due course, our findings
may provide opportunities to interact with/participate in NIAID-funded clinical trials, such as those currently
assessing DCreg therapy in organ transplantation at the University of Pittsburgh. Recent data show that
activation of the inhibitory leukocyte immunoglobulin-like receptor B (LILRB) family member LILRB3 (ILT5;
CD85a) that is highly expressed on DCs, confers profound immunoinhibitory functions on myeloid cells that
induce T cell tolerance to alloAgs in humanized mice. We will test our hypothesis that an agonistic LILRB3 mAb
can extend graft survival/allow IS withdrawal. An alternative novel approach to selective targeting DCs in situ is
use of Ab-directed DC-targeting nanobiologics. We hypothesize that nanoparticles (NP) functionalized with mAb
against the endocytic receptor DEC205 and loaded with the mTOR inhibitor rapamycin (mTORi-NP) will promote
Treg generation, extend graft survival and allow IS withdrawal. We discovered that acquisition of donor MHC Ag
via small extracellular vesicles (sEVs) and upregulation of co-inhibitory/anti-inflammatory molecules by recipient
DCs subverts anti-donor T cell responses in mouse liver transplant tolerance. In patients, infusion of DCreg
results in acquisition (via sEVs) of donor MHC, co-expressed with enhanced levels of co-inhibitory molecules on
host DCs. We hypothesize that infusion of autologous DCregs pulsed with donor sEVs (sEV-DCs) will extend
graft survival/allow IS withdrawal. Our Specific Aims:
Aim 1: To determine whether agonistic LILRB3 mAb combined with baseline immunosuppression can
extend kidney graft survival/allow IS withdrawal (n=12 transplants)
Aim 2: To ascertain whether selective targeting of DCs in situ using novel DC (DEC205)-directed
nanoparticles (mTORi-NPs) can extend graft survival/allow IS withdrawal (n=6 transplants)
Aim 3: To assess whether post-transplant infusion of autologous DCregs pulsed with donor sEVs (sEV-
DCregs) can extend graft survival/allow IS withdrawal (n=12 transplants)
This proposal incorporates the opportunity to further enhance overall program synergy by combining a DC-
targeting strategy shown to be effective here in Project 1 (we propose DEC205-directed mTORi-NPs;
alternatively, agonistic LILRB3 mAb) with donor alloreactive CARTregs, as described in Project 2, Aim 3.